CARDIOVASCULAR HEALTH AND STRESS

The purpose of this study is to determine the effects of race, age, gender and casual blood pressure elevation on stressor-induced opioidergic mechanisms that may contribute to the pathogenesis of essential hypertension.